Mechanisms that Regulate Antibody Class Switch Recombination and Somatic Hypermutation

Project Summary/Abstract of Research Plans for the Extension Period
The first two specific aims of this R37 grant were to test our hypothesis that cohesin-mediated loop
extrusion plays a key role in lgH class switch recombination (CSR) and lg variable region exon somatic
hypermutation (SHM). A third aim was to test our hypothesis that Peyer's Patch (PP) germinal centers(GCs)
expand rare V(D)J clonotypes with high intrinsic SHM levels. For these studies, we developed powerful assays
for CSR, SHM and chromatin interactions. We also employed our RAG2-defcient blastocyst complementation
approach (RDBC) to generate ES cell-based V(D)J passenger allele and V(D)J-rearranging mouse models for
in vivo studies. Despite pandemic challenges, we made substantial progress in the first 3.5 years.

Public health relevance
RELEVANCE (See instructions): Our proposed studies will further elucidate the mechanism of chromatin loop extrusion-mediated lgH CSR, test the role of loop extrusion in SHM and also address the function of recurrent BCR clonotypes expressed in chronic intestinal Peyer's Patch germinal cente rs. To address these questions, we are applying a host of powerful new technologies developed by our lab. The proposed work should advance our understanding of key antibody maturation mechanisms and may provide insights into potential roles of Peyer's Patch germinal center antibodies with respect to involvement in normal physiology or disease.